Identifying factors associated with ovarian cancer recurrence using a population-based approach

Ovarian cancer is the fifth leading cause of cancer related mortality in the United States. Despite advances in
surgical approaches and treatment regimens, overall survival has improved only marginally over the past thirty
years. Although nearly 80% of ovarian cancer patients will achieve complete clinical remission through surgery
and systemic therapy at their initial diagnosis, more than 50% will experience a recurrence by five years after
diagnosis. However, little is known about factors contributing to risk of ovarian cancer recurrence. Ovarian
cancer is a heterogeneous disease with distinct histotypes that inform prognosis. High grade serous carcinoma
is the most common histotype, comprising ~70% of all ovarian cancer diagnoses. Recently, three robust gene
expression signatures have been developed that have the potential to inform patient prognosis and biomarker-
driven therapeutic approaches. These tumor gene expression signatures include: a) the Milstein prognostic
score that distinguishes individuals with high and low probability of survival; b) the PrOTYPE classifier, which
categorizes four biologic subtypes; and c) the Oxford classifier, which identifies a poor prognosis epithelial-to-
mesenchymal transition score. Each signature correlates to differential with survival, suggesting that the
signatures may have clinical utility in informing patient prognosis; however, the scores have yet to be evaluated
in a population-based setting. Thus, the overarching goal of this proposal is to understand patient
demographic, clinicopathologic, and molecular features associated with patterns of ovarian cancer recurrence
and mortality. To do this, I will leverage the robust resources through the Utah Population Database to achieve
the following study aims: (1) Characterize patterns of ovarian recurrence and mortality by patient and
clinicopathologic characteristics; and (2) Compare the performance of three prognostic tumor gene expression
signatures with (a) mortality and (b) recurrence among high-grade serous ovarian cancer patients. The primary
training experience will focus on three areas: first, to develop expertise in the development and validation of an
algorithm to identify recurrence using multiple data streams; second, to develop expertise in transcriptomics
and data analysis pipelines for gene expression profiling; and third, to foster professional and career
development through leadership, scientific communication, and then transitioning to independence. The
research and training will be supported by an interdisciplinary mentorship team led by Dr. Jennifer Doherty,
and comprised of experts in ovarian cancer and genetic epidemiology, computational biology, and biostatistics.
The results from these aims will expand our understanding of factors contributing to risk and timing of ovarian
cancer recurrence and provide evidence on how gene expression signatures of high-grade serous ovarian
cancer can be incorporated into clinical risk assessment. Cumulatively, information gleaned from this work
could lead to a personalized approach to ovarian cancer disease management through inclusion of prognostic
markers in clinical care and the development of biomarker-driven therapies.

Public health relevance
Project Narrative Ovarian cancer recurrence affects more than 50% of ovarian cancer survivors; however, little is known about specific factors contributing to ovarian cancer recurrence risk. The proposed research project will identify recurrence patterns on a population level, and evaluate the associations of patient, clinicopathologic factors, and gene expression signatures with patterns of ovarian cancer recurrence and mortality. Information gleaned from this proposal may improve identification of patients at higher risk for ovarian cancer recurrence, thereby informing clinical decision-making and leading to alternative therapeutic strategies and patient follow-up.